Mouse Phenome Project

PROJECT SUMMARY
The goal of the Mouse Phenome Project is to support biomedical research by delivering a widely-accessed
and highly functional data repository for well-documented disease-relevant phenotypic data from
heterogeneous mouse populations. Studying model organisms can provide insight, aid in prioritization, and
facilitate translation of research findings into practice by improving the interpretation of modeling and
understanding human disease with insights gained from mouse phenotypic analysis across diverse
populations. Broader global data integration is needed such that data can come from across populations with
new representations, visualizations, and imputations. Better interoperation is needed to bring the data closer to
human genetics with improved user interfaces for more efficient data selection such that less “mouse insider”
insight is required. Our objectives are to provide a central repository for more breadth and unification of human
disease-relevant data and better representation of measurement relevance to disease states, offering a unique
and important venue for investigators needing to make their data public through NIH Data Management and
Sharing Plans; to continually refine and develop tools and features to best locate, present, and analyze those
datasets; and to maintain, enhance, and promote this resource to further enable quantitative, standardized and
predictive phenotype studies and, in turn, facilitate new scientific advances. We will achieve these objectives in
three Specific Aims. Aim 1: We will expand the Mouse Phenome Database to include more extensive
phenotype data by curating, annotating, organizing, and archiving those data to enhance interpretative use of
MPD and improve the representation of measurement-to-trait annotations. Aim 2: We will enhance the MPD
tool set to enable multivariate biostatistical and statistical genetics analysis to support use of phenotypic data
to interpret and model genetic variation in human disease. Aim 3: We will enhance the implementation of MPD
as a set of modern APIs to enable more versatile machine access and to expose mouse data to quantitative
analysis in light of human disease and other model organism empirical studies. Impact: The proposed efforts
will help maximize the value of these data and provide the traceability and scientific rigor required for extension
and translation. Completion of the proposed work will result in a powerful, interoperable system for public
access to and analysis of mouse phenotype data and will ultimately provide researchers a seamless
experience for the extrapolation of model organism genetics data to human genetic variation.

Public health relevance
RELEVANCE TO HUMAN HEALTH Substance use disorders are chronic diseases with limited treatment options, creating a significant legal, social, and public health burden. Historically, these and many other complex diseases have been investigated using mouse genetic approaches, but extrapolation of results from mouse studies to human populations remains a challenge. The Mouse Phenome Database is a widely used platform that meets this challenge through sharing of well-documented mouse data, protocols and analytic tools that enable researchers to integrate and analyze information across studies, to make use of the power, precision and depth of biological investigation possible in mice to bring greater understanding of the role of genes and variants in human disease.